Enhancing Physical Therapy with Brain Stimulation for Treating Postural Instability

Proprietary: This proposal includes trade secrets and other proprietary or confidential information of Highland Instruments and is being provided for use by the National Institutes of Health (NIH) for the sole purpose of evaluating this SBIR proposal. No other rights are conferred. This proposal and
the trade secrets and other proprietary or confidential information contained herein shall further not be disclosed in whole or in parts, outside of NIH without Highland Instrument's permission. This restriction does not limit the NIH's right to use information contained in the data if it is obtained from
another source without restriction. This legend applies to the entire proposal, including, but not limited to the Abstract, Introduction, Specific Aims, Research Plan (all components), Commercialization Plan, and Human Subject's Sections of this proposal.
Abstract
In patients with Parkinson’s Disease (PD), postural instability is a leading cause of disability, dependence on
others, and mortality. Current treatments for PD, including pharmacological and surgical methods, have limited
impact on postural instability. Physical therapy (PT) for PD is becoming increasingly used as a means to
induce exercise-dependent plasticity that can result in significant benefits for patient balance. However, PT is
still untailored to each patient need, and has not been optimized to work synergistically with other therapies in
PD. In recent years, there has been an increased interest in the use of noninvasive brain stimulation (NIBS)
devices for the treatment of PD and in their ability to couple their effects with PT regimens. But, ultimately
conventional NIBS methods have showed minimal and inconsistent effects on PD symptoms, and in particular
patient balance. It has been postulated that these techniques’ limitations in focality, penetration, and targeting
control translate into their limited therapeutic effects. Electrosonic Stimulation (ESStim™) is an improved NIBS
modality that overcomes the limitations of other technologies by combining independently controlled
electromagnetic and ultrasonic fields to focus and boost stimulation currents via tuned electromechanical
coupling in neural tissue. This proposal is focused on evaluating the therapeutic impact of ESStim in PD
patients as adjunct therapy to PT. First in Phase I, we will follow 18 PD patients (9 SHAM ESStim, 9 active
ESStim) undergoing PT after giving a fixed dose of ESStim for 10 days of stimulation, 20 mins/day, over a two-
week period. We will assess a battery of electrophysiology, cognitive, and neurological safety markers;
balance; Quality of Life (QOL) tests; the Unified Parkinson’s Disease Rating Scale (UPDRS); and sensor-
based, biomechanical metrics during bradykinesia, posture, and walking abilities/gait tests over the 2-week
period and for at least six weeks following the last treatment session. Next in Phase II, we will follow 40 PD
patients (20 SHAM, 20 active ESStim stimulation) after providing treatment over a month (i.e., increasing
treatment by 2 weeks), and assess the patients as above, but now for at least 8 weeks after treatment ends.
Finally, we will test whether the effects of ESStim enhanced PT training for postural instability in PD can be
guided by the baseline disease state and the effective dose of stimulation. To test this we will build and
evaluate multivariate linear and generalized linear regression models to predict the clinical outcomes. We will
also build MRI derived models of the stimulation fields in the brain (electrical and sonic field models) of each of
the PD subjects and correlate the stimulatory field characteristics with therapeutic outcomes. Overall, we
hypothesize that the proposed experiments, computational studies, and technology development will allow us
to test the effectiveness of ESStim as adjunct therapy to PT in PD patients. The results of the proposed work
will serve as the basis for a future large-scale multicenter study to further validate the technique and optimize
the methodology of ESStim coupled with PT for use in PD therapy.

Public health relevance
Project Narrative In patients with Parkinson's Disease (PD), postural instability is a leading cause of disability, dependence on others, and mortality. Current treatments for PD, including pharmacological and surgical methods, are not specifically designed to improve balance, and as such their effects on this symptom are limited. This study analyzes the impact of noninvasive brain stimulation treatments coupled with physical therapy for improving postural instability in PD patients.